Small Molecule Discovery Shared Resource

Small Molecule Discovery Shared Resource: Summary/Abstract
The Small Molecule Discovery Shared Resource (SMD) leverages the success of the UCSF Small Molecule
Discovery Center to expand dedicated support to cancer projects. The UCSF Small Molecule Discovery Center
was established in 2005 to alleviate key bottlenecks that hinder translation of new biology into first-in-class
small molecule therapies that benefit patients. The SMD is defined as the current and future support of cancer-
related projects therein, which range from Target Validation to Lead Optimization. The SMD advances cancer
projects from screening to chemistry to proof-of-concept in animal models by (1) increasing the number of
cancer-related projects that advance from screening to medicinal chemistry, and (2) augmenting HDFCCC
efforts in precision medicine and imaging within the Programs.